Role of the enterococcal site 2 protease in biofilm formation, adaptation, and host-pathogen interactions

PROJECT SUMMARY/ABSTRACT
Enterococcus faecalis significantly contributes to the burden of escalating healthcare costs as a leading cause
of healthcare-associated infections. The antimicrobial-recalcitrant nature of E. faecalis and its ability to form
biofilms necessitates prolonged and complex treatment strategies for infections. Therefore, there is a critical
need to identify new approaches for treating and preventing enterococcal disease. We previously showed that
the conserved intramembrane metalloprotease Eep, part of the site 2 protease (S2P) family, is a critical factor in
E. faecalis for both in vitro biofilm formation and in vivo biofilm-associated infection. This largely uncharacterized
role of Eep in E. faecalis biofilm formation is in addition to its documented functions in cell-cell signaling, cellular
adaptation in response to attack by the innate immune system effector molecule lysozyme, and the spread of
antibiotic resistance-carrying plasmids. However, despite its importance in these cellular processes, there are
numerous unanswered fundamental questions about Eep’s biochemical activity and how that activity influences
E. faecalis pathogen-host interactions. More broadly, our mechanistic and biological understanding of Eep and
orthologous S2Ps in other Gram-positive pathogens is also limited. This project will investigate the following
questions: (1) What are Eep’s substrates and products?; (2) How do Eep’s effectors affect biofilm formation and
adaptation to cell surface stress? In turn, how do these Eep-dependent processes affect host-pathogen
interactions?; and (3) How does Eep’s structure influence its ability to recognize and cleave substrates? Our
experimental design will test the hypothesis that the proteolytic activity of Eep leads to coordinated changes at
the cell surface that influence E. faecalis interactions with mammalian hosts in pathogenic settings. We will pair
proteomic, molecular genetic, and microbiological approaches with two animal models of in vivo biofilm formation
to identify candidate Eep substrates and downstream effectors in biofilms (Aim 1), characterize the genetic and
biochemical basis of cell surface alterations that render E. faecalis cells resistant to lysozyme (Aim 2), and
determine the key structural regions and amino acids in Eep that contribute to its function (Aim 3). Completion
of the proposed experiments will provide fundamental new knowledge about the functions and mechanism of a
conserved enzyme that will be translatable to other pathogenic bacteria that are associated with antibiotic
resistance and biofilm infections, such as methicillin-resistant Staphylococcus aureus and Clostridium difficile.

Public health relevance
PROJECT NARRATIVE Enterococcus faecalis is a leading cause of healthcare-acquired infections that are often associated with biofilm formation and antibiotic resistance. The goal of this project is to gain fundamental knowledge on the biological function and mechanistic activity of an enterococcal membrane protease that contributes to biofilm formation, antibiotic resistance transfer, and evasion of the host innate immune response. These studies will provide insights on the broad functions of the membrane protease in host-pathogen interactions and may lead to the development of strategies to control biofilm infection and antibiotic resistance gene transfer.